Identifying determinants of rapid structural and/or clinical progression in knee osteoarthritis by quantitative assessment of structural features on radiographs

Osteoarthritis (OA) is the most common musculoskeletal disorder and presents a large societal burden. Knee
pain in patients with knee OA is a leading contributor to physical disability and a major reason for hospital
visits. An improved understanding of the etiology of knee pain has been hampered in part by knee OA being a
multifactorial and progressive disease of the whole joint; consequently, knee pain progression may be the
result of local or regional abnormalities of several different structural features over time. The long-term goal is
to accelerate the development of optimal screening for enrollment into clinical trials to test promising
treatments for symptom improvement. The overall objective in this application is to study the association of
different MRI-based features with the temporal patterns of various knee pain measurements (e.g., knee pain
frequency and severity) in OA. The central hypothesis is that there are some temporal knee pain phenotypes
and various MRI-defined structural features (e.g., bone marrow lesions) are associated with the phenotypes.
This hypothesis is formulated largely based on the preliminary studies, including the Osteoarthritis Initiative
(OAI), the Multicenter Osteoarthritis Study (MOST), the semi-quantitative (SQ) readings, the complex knee
pain measurements in the OAI and MOST studies, and projects on machine/deep learning to accurately
predict SQ readings for MRIs that do not have existing radiologist-derived readings in the OAI and MOST
studies. The central hypothesis will be tested by pursuing two specific aims: 1) identify different temporal knee
pain phenotypes based on all available longitudinal knee pain measurements and the related knee pain risk
factors in the MOST and OAI; and 2) associate the MRI-defined structural features at baseline with the
identified temporal knee pain phenotypes. The research proposed in this application is innovative in several
ways. It considers various definitions of knee pain and the available pain measurement data in the super-
large longitudinal OAI and MOST studies and applies machine learning, deep learning and statistical methods
to identify knee pain phenotypes and associate them with MRI-based factors. This new and substantively
different approach to understanding knee pain is expected to overcome the limitations of existing studies
(e.g., single knee pain measurement-based and cross-sectional studies), thereby opening new horizons for
detecting different temporal knee pain phenotypes and allowing identification of individuals at high risk of
various temporal knee pain phenotypes for more targeted enrollment into clinical trials.

Public health relevance
The proposed research focuses on novel application of machine learning and statistical approaches with improved power and higher prediction accuracy to identify temporal knee pain phenotypes and analyze their association with various MRI-defined structure features such as Bone Marrow Lesion (BML) and Effusion Synovitis (ES). It is expected that the proposed studies will provide timely information that can help identify patients who would be most likely to benefit from pharmacologic and non-pharmacologic interventions to prevent or slow the progression of knee OA. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to reducing illness and disability.